Refractive surgery for ASD

Career Goal: 1. To further define the role of visual morbidity and autism spectrum disorder phenotype. 2. To
understand the role of visual development in ASD morbidity guided by fcMRI biomarkers in both sighted and
children with visual comorbidities.
Research Project: Autism spectrum disorder (ASD), which affects 2% of individuals in the population, is defined
by deficits in social communication and restrictive and repetitive behaviors. ASD is characterized by etiologic
heterogeneity with contributions from multiple genes, environmental factors, and co-occurring neurological and
mental health comorbidities. ASD is 30 times more common in children with congenital blindness, and decreased
visual acuity among a population with comorbid social deficits can be particularly burdensome. 20-44% of
children with ASD have visually significant refractive error. Yet, 31% of ASD children (vs. 4% typically developing
children) are unable to wear glasses even though their vision is secondarily degraded to the point of legal
blindness. Refractive surgery can improve visual acuity in this population. We recently published the results of a
pilot study of 24 children pre- and 1-month post- refractive surgery. In addition to gains in visual function, we
showed that Social Responsiveness-2 (SRS-2) social awareness scores improved by a median of 15 points
post-surgery. The objective of the present study is to quantify improvements in visual acuity (Teller acuity testing),
adaptive behavior (Vineland), and social responsiveness (SRS-2) post refractive surgery. We hypothesize that
in addition to gains in visual function, SRS-2 and Vineland-3 scores will improve in ASD children post-refractive
surgery. If these benefits are validated, pediatric refractive surgery could easily be disseminated, with guidelines
informed by this study (and subsequent R01), as thousands of centers throughout the world already routinely
perform refractive surgery on adults. Furthermore, the proposed study will tangibly impact the basic science of
ASD – regarding the role of decreased visual acuity as a comorbid, contributing, or actively reinforcing factor –
by clarifying the visual system and cognitive neuroscientific underpinnings of treatment effects on vision and
behavior in this population versus other ASD populations.
Career Development: This K23 award will provide me with the necessary training in the areas of behavioral
phenotyping of ASD children, as well as the concepts and methods of functional neuroimaging. Training will
occur at Washington University School of Medicine, which is a highly collaborative scientific environment and a
leading institution for ASD, pediatric ophthalmology, and neuroimaging.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorder (ASD) is marked by deficits in social communication, restrictive and repetitive behaviors, and often, has comorbid abnormal visual behaviors. This study will characterize how improved visual acuity secondary to refractive surgery influences social deficits as measured by Social Responsiveness-2 Scores (SRS-2), adaptive behaviors as measured by Vineland-3, and ASD symptoms measured by Brief Observation of Social Communication Change (BOSCC). Understanding the impact of improved visual acuity on social deficits and adaptive behaviors reveals important insight into the role of vision and visual acuity on ASD phenotype, and potentially, lays the foundation for future study to further define the relationship between visual morbidity and ASD phenotype and understand the role of visual development in sighted and visually impaired individuals in ASD.